Exploring Margaric Acid Role in Alcohol-Associated Liver Diseases

Alcohol-associated liver diseases (AALD) account for over 5% of global health problems, and alcohol abuse
is a causal factor in more than 200 diseases. Endotoxemia and systemic inflammation are common conditions
associated with morbidity and mortality in various AALD. Extensive clinical and experimental evidence indicates
that disruption of intestinal epithelial tight junction and mucosal barrier dysfunction are prerequisite steps in
alcoholic endotoxemia, systemic inflammation, and AALD. Therefore, the gut is a crucial target for developing
therapeutics for AALD. A critical barrier in this field is that the mechanism underlying alcohol-induced TJ
disruption is poorly defined. Our long-term goal is to describe the pathophysiology of AALD and develop novel
therapeutic strategies by targeting gut barrier dysfunction. Our preliminary studies show that: 1) margaric acid
levels in the plasma from patients with severe alcoholic hepatitis were significantly low compared to healthy
subjects. 2) The plasma level of heptadecenoic acid (C17:1), the unsaturation metabolite of margaric acid, was
increased in patients with severe alcoholic hepatitis. 3) Pretreatment of Caco-2 cell monolayers (an established
model of the intestinal epithelium) with margaric acid-reduced ethanol (EtOH) and acetaldehyde (MeCHO)-
induced TJ disruption and epithelial barrier dysfunction. 4) Margaric acid elevated Caco-2 cell rigidity (analyzed
by atomic force microscopy) and attenuated EtOH and MeCHO-induced reduction of cell rigidity. These findings
form the scientific premise and support the central hypothesis that margaric acid supplementation attenuates
alcohol-induced gut and liver injury. We will test this hypothesis by determining that 1) Margaric acid dose-
dependently attenuates alcohol-induced remodeling of the actin cytoskeleton in the intestinal epithelium, 2)
Margaric acid prevents alcohol-induced disruption of TJ and AJ in the intestinal epithelium, 3) Margaric acid
supplementation of the diet attenuates alcohol-induced gut and liver injury in a dose-dependent manner, and 4)
Margaric acid (C17:0) to heptadecenoic acid (C17:1) ratio drives alcohol-induced gut and liver injury. The
expected outcome of these studies will help establish the therapeutic potential of margaric acid in treating
alcohol-associated diseases.

Public health relevance
According to the CDC (Centers for Disease Control and Prevention), the average mortality caused by excessive alcohol consumption increased by 29.3% from 2016-2021 in the United States. More than 18 million Americans are estimated to have alcohol-associated liver diseases (AALD), including hepatitis, pancreatitis, fibrosis cirrhosis, fatty liver (steatosis), and neurodegenerative disorders. We propose to conduct studies to uncover the pathophysiology involved in alcohol-mediated gut barrier dysfunction, endotoxemia, and liver injury and determine the role of margaric acid in treating AALD.